Gene Therapy for Xeroderma Pigmentosum - Cockayne Syndrome.

PROJECT SUMMARY
The goal of this project is to refine our gene therapy strategy for Xeroderma Pigmentosum-Cockayne Syndrome
(XP-CS), with the ultimate aim of improving the neurological outcomes and life expectancy for this disorder. XP-
CS is a rare, inherited DNA repair disorder that is characterized by an accelerated aging phenotype and
prominent, severe neurodegenerative complications mirroring those seen in classic Cockayne syndrome (CS),
including cognitive dysfunction, brain atrophy, neurodevelopmental delays, peripheral neuropathy, brain atrophy,
and dementia. There are several genetic subtypes of XP-CS, including one associated with pathogenic variants
in the gene ERCC5 (XPG). We have found that the Xpg-/- mouse accurately recapitulates key features of the XP-
CS phenotype, including neurological features. We have also developed a first generation adeno-associated
virus (AAV) vector capable of delivering ERCC5 that shows great promise but requires further development prior
to translation into human clinical trials. Our preliminary studies using the first generation vector in the Xpg-/-
mouse point to a clear path towards optimizing this approach, including capsid optimization, promoter
optimization, delivery optimization, dose tuning, toxicity studies, and biomarker evaluations. We expect that our
proposed studies will lead to a gene therapy strategy that overcomes many of the obstacles to translation into a
Phase 1 human clinical trial. The knowledge obtained from these studies will be generalizable, and will accelerate
the development of gene therapies for other genetic subtypes of XP-CS.

Public health relevance
PROJECT NARRATIVE Xeroderma pigmentosum-Cockayne syndrome (XP-CS) is a rare, severe genetic syndrome that has characteristics of two classic DNA repair disorders that are usually clinically distinct: XP and CS. We have characterized a mouse model for one genetic subtype of XP-CS (XPG) and have designed a gene therapy vector to treat the severe neurodegeneration and extend lifespan in these mice. The goal of this project is to refine our gene therapy strategy to optimize efficacy and safety in preparation for translation of this approach into human clinical trials.